The Role of IL-II in the development of autoimmune response in multiple sclerosis

Multiple sclerosis (MS), a central nervous system (CNS) inflammatory demyelinating disease, is a
leading cause of disability in the young adult population. While dramatic progress has been made in
our understanding of the disease pathogenesis, the initial disease-­triggering events remain poorly
understood. Since immunomodulatory therapies are most effective when administered early in the
course of the disease, we are seeking biomarkers of the clinically isolated syndrome (CIS) suggestive
of MS, the earliest phase of the disease. Our preliminary studies have identified IL-­11, a new Th17
cell-­polarizing cytokine, as the most significantly increased cytokine in the serum and cerebrospinal
fluid (CSF) of CIS patients, whose serum levels are increased during clinical exacerbations of the
disease. CD4+ cells are the main source of IL-­11 in the peripheral circulation. The percentage of IL-­
11+CD4+ cells is increased in the peripheral circulation of CIS patients in comparison to matched
healthy controls (HCs), and they significantly accumulate in the CSF and the active brain MS lesions in
comparison to matched blood samples. Animal studies have confirmed the causal role of IL-­11 in the
exacerbation of relapsing remitting (RR) experimental autoimmune encephalomyelitis (EAE), since IL-­
11 administration worsened clinical course and induced increased numbers of IL-­17A+CD4+ cells in the
central nervous system (CNS) inflammatory infiltrates. Our central hypothesis is that IL-­11 induces
CD4+ cell migratory capacity and encephalitogenicity, mediated via up-­regulation of CCR6, ICAM-­1 and
VLA-­4, which mediate CD4+ cells trans-­endothelial migration. We propose that IL-­11+CD4+ cells, which
are also expanded in the presence of IL-­11, may represent a pathogenic cell subset, whose
transcriptional profiling and T cell receptor (TCR)Vb repertoire will elucidate their function and antigen
specificity. aIL-­11R mAb treatment of RRAEA will provide pre-­clinical data and identify markers of
therapeutic effect for this new therapeutic approach. The objective of this study is (1) to identify the
molecular mechanisms involved in IL-­11-­induced migration of CD4+ cell subsets to the CNS in CIS
patients, (2) to characterize the phenotype, transcriptional profile and TCRVb repertoire of CSF-­
enriched IL-­11+CD4+ cells in CIS patients, and (3) to examine the potential of IL-­11 to induce
encephalitogenic CD4+ cells capable of passively transferring disease, and to determine the therapeutic
effect of aIL-­11R mAb in RREAE, an animal model of the disease. The results are expected to provide
biomarkers of early autoimmune response in CIS patients and to identify selective therapeutic targets
for this disabling disease.

Public health relevance
Project Narrative: This study will characterize the role of IL- 11 in the pathogenesis of relapsing remitting multiple sclerosis (MS). Based on our preliminary results on the increased IL- 11 serum and cerebrospinal fluid levels in patients with the earliest clinical presentation of MS, and causal role of IL- 11 in exacerbating experimental autoimmune encephalomyelitis (EAE), our studies will characterize the capacity of IL- 11 to induce encephalitogenic CD4+ cells. IL- 11+CD4+ cells are enriched in the cerebrospinal fluid and MS brain lesions. We will characterize their transcriptome and TCRVb repertoire. Therapeutic potential of anti- IL- 11R mAb will be tested in preclinical EAE model.